Rescuing Visual Perception in Aging Adults by Restructuring the Alpha-Gamma Neural Code

PROJECT SUMMARY/ABSTRACT
In the past century, age-related deficits and dementia have surged, and this trend is expected to intensify with
the rapidly aging global population. The decline in visual perception associated with aging significantly impacts
health, well-being, and overall quality of life. Key aspects of the visual system, namely contrast sensitivity (the
ability to distinguish objects from their backgrounds) and 3D structure-from-motion perception (the capacity to
recover depth structure from object motion), undergo pronounced deterioration with age and in age-related
diseases, such as Alzheimer's disease (AD). These functions are fundamental to human vision, highly
informative of everyday perception, substantially compromised in aging and AD, and predictive of AD-related
biomarkers, pathophysiology, and disease severity. Despite advancements in understanding age-related
perceptual deficits, neurocomputational insights are lacking, and there are currently no available treatments for
impaired perception in older age. Neuroscience theory suggests that the interaction between alpha (8-12 Hz)
and gamma (>30 Hz) neural oscillations may indicate a cortical signaling state for optimum visual perception
efficiency. This state is achieved when gamma power peaks phase-synchronize to troughs of the alpha cycle,
facilitating the integration of feedforward (gamma) and feedback (alpha) information streams. We propose to
investigate the neurocomputational mechanisms underlying age-related perceptual impairments across the
adult lifespan, focusing on the dynamic phase structure of interacting low- and high-frequency
electrophysiological oscillations. Our approach employs functional and structural magnetic resonance imaging
(f/MRI) and high-density electroencephalography (EEG), combined with source reconstruction techniques, to
investigate the role of alpha-gamma phase amplitude coupling in age-related visual perception deficits. We will
construct personalized high-definition transcranial alternating-current stimulation (HD-tACS) protocols in an
effort to manipulate alpha-gamma interaction, steer contrast sensitivity and motion perception bidirectionally,
and restore these functions in older adults. Encouraging preliminary data suggest the potential to causally
manipulate the synchronization between alpha and gamma dynamics, resulting in improved contrast sensitivity
and 3D shape perception in older adults. Furthermore, altering the phase preference of alpha-gamma
interaction appears to rapidly influence psychophysical mechanisms, causing improvements or impairments in
perceptual abilities for younger adults. The overarching goals of this research program are to leverage
innovative neuroscience tools and analytic procedures to deepen our understanding of the brain mechanisms
behind age-related perceptual impairments. Ultimately, the findings aim to contribute new knowledge to the
future development of effective, non-pharmacological interventions for enhancing visual perception in healthy
aging and Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE Impairments in visual perception are a central feature of normal brain aging and the rapid deterioration associated with dementias, such as Alzheimer’s disease. This project combines the measurement of synchronized electrophysiological oscillations with improved neuromodulation technology to provide original and otherwise unapproachable causal insights into the neurocomputational mechanisms of visual perception and its breakdown across the adult lifespan. This project also aims to lay the basic science groundwork for developing the next generation of drug-free strategies for improving perception in age-related neurodegenerative disorders.